PREcision Care In Cardiac ArrEst - ICECAP (PRECICECAP)

Project Summary
The objective of PREcision Care In Cardiac ArrEst - ICECAP (PRECICECAP) is to discover novel biomarker
signatures of post cardiac arrest brain and extracerebral organ failure that predict treatment responsiveness
and long-term recovery. We will achieve this by partnering with the ICECAP trial, a response-adaptive dose
finding clinical research trial that seeks to determine the optimal duration of post-arrest hypothermia. Cardiac
arrest is a major public health problem with high morbidity and mortality. Four in five patients hospitalized
after cardiac arrest have significant brain injury, and death from neurologic damage is common. Improving
survival and functional recovery is a critical public health objective and will require innovative approaches.
The current clinical situation is unprecedented. Currently post-CA brain injury is an acute, sudden critical
illness with major knowledge gaps about how best to characterize severity of injury and to identify which
individual patients are likely to benefit from specific neuroprotective strategies. Thus, development of high-
performing biomarker signatures is a critical need and would translate in to immediate changes in care. We
hypothesize that not all patients are identical (i.e. there will be a heterogeneity of treatment effect) and that
through our innovative, multi-parametric data driven approach, we will be able to identify novel signatures that
define subgroups of patients. Advanced data science and analytical approaches will allow the identification of
these subgroups that was previously not possible. These subgroups will be clinically important insofar as they
will indicate differential responses to treatment and different trajectories of functional recovery. This project
will acquire high resolution multi-modal data early in the disease course that will allow us to address these
current knowledge gaps and improve our understanding of the disease in the early acute setting when
interventions can improve outcome. The knowledge learned here will be applied to develop personalized
treatments for cardiac arrest survivors, addressing the NIH's and our goals of lengthening life and reducing
disability.

Public health relevance
Project Narrative Post-cardiac arrest injury affects the brain and other critical organs and is a major public health problem causing significant death and disability. This project will use novel data-driven approaches to collect high resolution monitoring data from patients in the critical care unit and will use that multi-parametric data to develop newly defined patient sub-groups with differing clinical trajectories and responses to therapies. This project will have a major impact on public health by allowing treatment of the right patient at the right time with the right therapy, thereby reducing disability and saving lives.